02 - Experimental Therapeutics

ABSTRACT – EXPERIMENTAL THERAPEUTICS (ET) PROGRAM
Overview and Goals: The ET Program is the major translational/clinical research engine of the O'Neal with the
goals of identifying novel targets and developing new imaging techniques that can inform innovative therapeutic
strategies and provide cancer patients with an enhanced opportunity for improved survival, increased freedom
from disease progression, and improved quality of life. Research Highlights: Discovery of new pre-clinical
targets such as LIMK2 and PAK4, their in vivo validation in pre-clinical models and medicinal chemistry efforts to
develop clinical grade inhibitors to these targets will provide novel therapeutic opportunities for triple-negative
breast cancer (TNBC) and bladder cancer patients, with direct implications for other cancer types in our catchment
area. Advances in imaging markers of patient response to immunotherapies, including hypoxia and granzyme B,
have led to clinical trials in breast cancer, melanoma, and non-small cell lung cancer, all of which are of importance
in our catchment area. Successful inter- and intra-programmatic collaborative bench to bedside efforts continue
to result in clinical translation, including novel combinations with EGFR and PARP inhibition in TNBC or EGFR
and DNA repair checkpoint inhibition in head and neck cancer. Program Activities: ET co-leaders work closely
with O'Neal leadership to enable intra- and inter-programmatic collaborations through program activities
enhanced by SPORE (Cervical cancer; P50 CA098252) and P01 funding (Cancer Prevention; P01 CA210946),
significant collaborations with Southern Research through the Alabama Drug Discovery Alliance, and
partnerships with industry. Strong collaborations with national consortia have continued, including the NCI NCTN
Lead Academic Partnership Site grant (UG1 CA233330) and the Translational Breast Cancer Research
Consortium. Members: The program has 60 members from 14 departments and 3 schools. NCI funding is $3.6M,
cancer-relevant, peer-reviewed funding is $7.8M, and total cancer-relevant funding is $23M. 2,065 patients were
enrolled in therapeutic trials over the current CCSG cycle, including 12% to investigator-initiated trials, 31% to
pilot/Phase I studies, 10% to Phase I/II trials, and 37% to Phase III trials. The program had 1,123 publications
over the current CCSG cycle including 34% inter-programmatic, 24% intra-programmatic, 68% resulting from
collaborations with other institutions, and 13% in journals with an impact factor of 9 or greater. Future Directions:
We plan to enhance current strengths in O'Neal cross-cutting research themes as laid out in the strategic plan,
namely obesity and metabolism in cancer, cancer immunology, imaging, target identification and therapeutic
development. We will work with the office of Community Outreach and Engagement to leverage recent support
e.g., Bridge the Transdisciplinary Cancer Research Continuum supplement (P30 CA013148-48S6), CATCH-UP
ETCTN supplement (P30 CA013148-48S3), Genentech AIR grant, and institutional infrastructure to bring the
newest innovative cancer treatments to the underserved population of Alabama.